Regulation of Argonaute Nuclear Import in Mediating Transgenerational Fertility

PROJECT SUMMARY
Nuclear RNA interference (RNAi) is a conserved gene regulatory pathway that is essential for transgenerational
fertility and genome stability. Mediated by Argonaute proteins and small RNAs, nuclear RNAi ensures proper
regulation of vital processes such as accurate gametogenesis, proper embryonic development, and transposon
silencing. Given their critical biological importance, defective and dysregulated Argonaute proteins are
associated with various reproductive and developmental disorders, as well as cancer formation and progression.
Since the nuclear RNAi pathway and the Argonaute protein structure are highly conserved, we can use C.
elegans to investigate these complex human disorders. Our long-term goal is to use C. elegans to characterize
the nuclear RNAi pathway, which will provide insight into the molecular biology that drives these human disorders
and how it affects fertility, development, and genome integrity. There remain critical outstanding questions
regarding the nuclear RNAi pathway. Firstly, Argonaute nuclear import remains poorly characterized, even
though it is imperative for nuclear RNAi. Secondly, the biological function of the N-terminal intrinsically disordered
regions (IDRs) of Argonaute proteins remains elusive. Thirdly, post-translational modifications (PTMs) and their
role in regulating nuclear Argonaute function are not well characterized. The objective of this proposal is to
determine the regulation and molecular mechanism of Argonaute nuclear import that mediates transgenerational
fertility. The proposal will address the central hypothesis that the N-terminal IDR of nuclear Argonaute protein
HRDE-1, is essential for small RNA-loading and that PTMs regulate HRDE-1 function and nuclear import. Aim
1 will elucidate the biological function of the HRDE-1 N-terminal IDR, using innovative experiments such as
CRISPR editing, small RNA-binding assays and sequencing, and fluorescence imaging. Importantly, we will
directly determine the effect on transgenerational fertility and RNAi inheritance in these mutants with phenotypic
assays. Aim 2 will characterize the role of PTMs in regulating HRDE-1 sRNA binding and nuclear import, utilizing
the experiments listed in Aim 1 as well as the phenotypic assays. Aim 3 will determine the factors and pathways
that mediate HRDE-1 nuclear import. Potential nuclear import factors have been identified and preliminary results
have verified two candidates to be true HRDE-1 nuclear import factors. We will continue screening other
candidates with RNAi gene knockdown and fluorescence imaging experiments. The physical interaction of
HRDE-1 and the nuclear import factors will be determined with co-immunoprecipitations. The expected results
of this proposal will determine the biological function of HRDE-1 N-terminal IDR, as well as identify the molecular
mechanism and factors that mediate HRDE-1 nuclear import. The overall impact of this research is that it will
provide valuable molecular insight into the conserved nuclear RNAi pathway, which will shed light on how
dysregulation of the pathway can lead to devastating human disorders.

Public health relevance
PROJECT NARRATIVE Nuclear RNA interference (RNAi) is a conserved gene silencing pathway that ensures transgenerational fertility, accurate development, and genome stability, and when the pathway is defective, it can lead to reproductive and developmental disorders, and even cancer. Argonaute proteins bind small RNAs and carry out RNAi-mediated gene silencing in the nucleus, but how specifically Argonaute proteins bind small RNAs and enter the nucleus remains unknown. This proposal will determine the molecular mechanism of Argonaute protein small RNA- loading and nuclear import, which will bring us one step closer to characterizing the nuclear RNAi pathway and how it can lead to these complex human disorders.